Modernization of Sterilization Equipment to Support Research at Emory National Primate Research Center

Abstract
To meet the current and projected future research demand (over $94 million in research grants
in FY24), the Emory National Primate Research Center (EPC) is proposing to acquire a modern
chlorine dioxide-based sterilizer for ensuring continuous research support. The proposed new
sterilizer will provide a safer unit for personnel and a more environmentally friendly unit that
adheres to both new Environmental Protection Agency (EPA) and Food and Drug
Administration (FDA) recommendations. In addition, the new sterilizer has a larger capacity to
hold more instruments per cycle and a significantly shorter cycle time which will allow the EPC
to improve efficiency in processing. Providing sterilization support is critical to support the
EPC’s robust translational research programs focusing on infectious disease, neuroscience and
transplant medicine. Purchasing this chlorine dioxide-based sterilizer will allow the EPC to
provide continuous support to advance NIH-funded research for both internal and external
collaborators, while increasing operational efficiency, creating a safer workplace, and protecting
the environment.

Public health relevance
Project Narrative This S15 application is seeking funding to acquire a modern chlorine dioxide sterilizer to proactively replace an aging ethylene oxide sterilizer to ensure continuous support of the Emory National Primate Research Center robust research portfolio. Upgrading the sterilizer to chlorine dioxide will provide a safer unit for personnel and a more environmentally friendly unit that adheres to both new Environmental Protection Agency (EPA) and Food and Drug Administration (FDA) recommendations, while also providing a larger and shorter cycle time which will allow EPC to improve efficiency in processing. Obtaining this new sterilizer will allow us to provide continuous support for the extensive translational research portfolio at EPC.